Molecular Pathology Shared Resource

MOLECULAR PATHOLOGY SHARED RESOURCE: PROJECT SUMMARY
The Molecular Pathology Shared Resource (MPSR) facilitates tissue-based research by the acquisition,
processing and characterization of tissues, providing related data, material and diverse expertise that enables
discovery, characterization and validation. It does so through three integrated services: (1) tumor banking; (2)
histology and related services including immunohistochemistry (IHC) and immunofluorescence (IF), tissue micro-
array construction, image digitalization and analysis and tumor review by board certified pathologists; and (3)
consultation and project management services. Directed by Hanina Hibshoosh, MD, the MPSR is staffed by
dedicated/certified histotechnologists, immunohistochemistry experts, board-certified pathologists, a PhD-level
molecular biologist, physician assistant, and database experts. During the current project period (2014-2019),
the MPSR fulfilled 13,004 service requests from 107 HICCC members The MPSR allows for seamless integration
of services that span from tumor capture, tissue processing, hematoxylin and eosin
(H&E)/Immunohistochemistry (IHC) generation and expert review, microdissection, and DNA/RNA/protein
extraction in preparation for multi-omics characterization. MPSR banking services are comprehensive,
innovative, and unique allowing investigators to participate in trials/projects (e.g., Oncology Phase I program, N-
1 master regulator analysis, NCI Early Onset Malignancy program and NCI Patient Derived Models Tissue
Procurement Protocol) knowing they can effectuate their specific tissue based requirements by an efficient “plug
and play model” requiring only a single notification. MPSR’s Next Generation banking platform has enabled
research in breast (PTEN discovery and characterization), pancreas (enabled recruitment and research) and
participation in The Cancer Genome Atlas. MPSR’s extensive user base is cost-, quality-, and efficiency-sensitive
and has chosen the MPSR to provide services in the highly competitive histology market, which a clear indicator
of the facilities value. The MPSR’s scale is reflective of value add, the utility of tissue analysis, as well as the
quality and breadth of our services, their cost effectiveness, efficient delivery of services, material (tumors, DNA,
RNA, proteins), data, and expertise that the MPSR provides its users. Over the current project period, the
capabilities of the MPSR were utilized by 107 HICCC members, supported key data and insights facilitating 57
HICCC member peer-reviewed publications including 23 contributions in journals with impact factor >10 of which
12 were in journals with an impact factor of greater than 20 (Nature, Nature Medicine, Nature Genetics, Genome
Medicine ). and currently supports research for 82 NIH-funded grants (41 from NCI).